Discovering antimicrobials acting against MDR pathogens

Abstract
We are experiencing an antimicrobial resistance crisis (AMR), a direct result of a decline in
antibiotic discovery. The WHO designated a list of priority pathogens, and of these, MDR Gram-
negative Enterobacteriaceae (E. coli, S. typhimurium, Klebsiella pneumoniae, Enterobacter),
Pseudomonas aeruginosa, and Acinetobacter baumannii) are of “critical priority”. These
pathogens are the focus of the present proposal aimed at developing a platform for efficient
discovery of novel antimicrobials. The field once enjoyed a golden era of discovery, fueled
mainly by screening of soil actinomycetes. All major classes of broad-spectrum antibiotics active
against Gram-negative pathogens were discovered by the 1960s. Overmining of actinomycetes
resulted in the collapse of the discovery platform. Novel antibiotics discovered since then only
act against Gram-positive species. We developed methods to access a broader range of
bacteria, with a focus on uncultured species that make up 99% of total biodiversity. A number of
novel compounds came from this source, including teixobactin, representing a new class of cell-
wall acting compounds without detectable resistance (Ling et al., 2015). Teixobactin is
undergoing IND-enabling studies; it is also a narrow-spectrum compound. We propose to
develop a platform for efficient discovery of novel antimicrobials. The main problem is the
enormous background of toxic, and to a lesser extent, known compounds. We hypothesize that
the bottleneck of dereplication can be resolved by differential screening that detects the
presence of a promising compound prior to dereplication. Using this approach, we recently
discovered darobactins that have a novel scaffold and target the essential outer membrane
protein BamA (Imai et al., 2019), and several additional novel compounds. In the proposed
project, we will develop an ultra-high throughput screen based on encapsulating producing
bacteria together with different fluorescently labeled reporters in microdroplets created in a
microfluidics device. Our preliminary data show that sorting droplets can be performed at a rate
of 106 a day, and leads to detection of producers of desirable antimicrobials. We will evaluate
several modalities of this screen, aimed at discovering selective as well as broad-spectrum
compounds acting against Gram-negative bacteria; and anti-persister compounds. The platform
is likely to be of use to the field of antibiotic discovery. Leads that come out of this screen will be
evaluated in vitro and in animal models of infection. Novel leads that come out of this project will
be ready to enter IND-enabling studies.

Public health relevance
We are experiencing an antimicrobial resistance crisis, with some pathogens becoming resistant to all available antibiotics. In this project, we introduce a novel discovery platform to efficiently identify antibiotics from environmental bacteria. This project will lead to badly needed compounds to fight important multidrug- resistant pathogens, and to treat chronic diseases.